Elucidating the role of IP6 in HIV-1 assembly, maturation, and infection.

PROJECT SUMMARY
The HIV/AIDS pandemic has claimed more than 36 million lives worldwide. Although effective antiretroviral drugs
are widely available, virologic failure due to drug toxicity and poor adherence leading to the development of
resistance is an increasingly serious problem. This highlights the need for continued development of novel HIV
inhibitors and a strong commitment to basic research aimed at elucidating the mechanisms driving HIV
replication, transmission, pathogenesis, and drug resistance. The cellular metabolite inositol hexakisphosphate
(IP6) is an essential co-factor for HIV-1 replication. IP6 promotes particle production in HIV-1 producer cells by
binding to and stabilizing the immature Gag lattice (IGL) and subsequently promotes particle infectivity by binding
to and stabilizing the capsid, which is assembled during particle maturation. Importantly, these functions of IP6
suggest interplay between IP6 and two classes of HIV inhibitors: maturation inhibitors (MIs) and capsid inhibitors
(CIs). During the mentored phase of this award, the applicant will investigate the separate roles of IP6 in each
of these key steps in the HIV-1 replication cycle, informing the development of novel MIs and CIs. A forced
evolution approach will be used in which replication-deficient mutant viruses will be propagated in T cell lines to
determine how HIV-1 adapts to the loss of IP6 binding. In Aim 1, the role of IP6 during IGL assembly and particle
production will be investigated. The interaction between IP6 and the IGL is hypothesized to ensure the packaging
of IP6 into viral particles at levels required to promote capsid assembly during maturation. HIV-1 Gag mutant
viruses that assemble independently of IP6 will be used to test this hypothesis. This work builds on the applicant’s
recently published research showing that the replication of Gag mutants deficient for IP6 binding can be restored
by IGL stabilization. In Aim 2, the role of IP6 binding to the HIV-1 capsid and the implications of this interaction
for capsid assembly and virion infectivity will be investigated. The capsid, which assembles in the virion, must
remain stable and intact during the post-entry steps of the virus replication cycle. Mutant viruses unable to
interact with IP6 in the context of the assembled capsid are highly deficient in replication and particle infectivity
due to an inability to assemble stable capsids. The mechanisms by which mutations within capsid that restore
capsid assembly and particle infectivity to capsids unable to bind IP6 will be studied using cell-based assays and
structural analyses via collaborations with expert investigators. In addition to research, the applicant will engage
in a wide variety of career development activities including technical training and management, leadership, and
diversity training. The applicant will also meet regularly with his advisory committee to discuss research progress
and to receive advice on the academic job search. During the independent phase of this award, additional factors,
including antiviral compounds, that affect capsid stability will be investigated. In Aim 3, the mechanisms of action
of novel CIs and pathways of resistance to these compounds will be investigated. Additionally, host factors that
affect capsid stability post-entry will be investigated in the context of CI activity and resistance.

Public health relevance
PROJECT NARRATIVE Despite major advances in treatment and care, HIV remains a threat to human health worldwide. The research proposed in this application will substantially improve our understanding of the viral and host factors that govern HIV-1 replication, particularly inositol hexakisphosphate (IP6) and other factors that influence capsid stability and key capsid functions. Ultimately, this work will inform the development of novel inhibitors blocking these essential functions and contribute to the effort to end the global HIV/AIDS pandemic.